Disparities in Trust: COVID-19's Impact on Minority Veterans' Healthcare Experiences

Background: Patients’ trust in their healthcare system has a profound impact on their health and well-being
and, as 1 of 4 overall key goals set by the Secretary of the Department of Veteran Affairs (VA), is a high priority
for VA. Our previous research found lower levels of trust and higher perceived discrimination amongst Black
and Latinx Veterans obtaining VA medical care compared to White Veterans. Considering the disproportionate
impact of the pandemic on minority communities and the overlap between racial and digital divides, it is
important to better understand the negative healthcare experiences of Black and Latinx Veterans in the
aftermath of COVID-19. This information will be critical to improve care through targeted recommendations.
Significance/Impact: Considering the disproportionate impact of COVID-19 on minority Veterans, the
potential differential effects of a radically transformed healthcare environment, and the need to implement
widespread vaccination and booster programs, our proposal focuses on an important VA priority. Our proposed
research is highly responsive to the call to ensure the VA meets its strategic goal of inspiring Veterans to trust
the healthcare system, as well as to HSR&D’s priority for actionable health equity research. VA also
recognizes the importance of understanding the source of racial/ethnic disparities in trust with VA medical care
in order to develop targeted recommendations to improve minority trust with VA health care.
Innovativeness: The proposed Disparities In Care Experiences (DICE) study uses a novel mixed methods
design that integrates the insights and richness of qualitative data collection with the precision of quantitative
data analysis. DICE will be able to traverse from detection, to understanding, to forming the basis for
interventions using Veterans’ own recommendations.
Specific Aim 1. To examine the associations between Veterans’ race/ethnicity and their trust in the VA by
conducting the DICE quantitative telephone survey with 1,050 Black, Latinx, and White male and female
Veterans from 25 VA Medical Centers who used VA outpatient or telehealth services, or had care deferred.
Specific Aim 2. To explore Veterans’ experiences contributing to trust in the VA by adding open -ended
qualitative questions to the DICE quantitative telephone surveys for a subset of 150 male and female Veterans
from our Aim 1 sample and to elicit actionable recommendations for improving Black and Latinx trust in VA.
Specific Aim 3. Using the Aim 1 survey results and the Aim 2 Veteran recommendations, we will work with our
operational partners and a key vendor to develop and disseminate a toolkit and training to empower VA
stakeholders to improve the healthcare system to engender trust amongst Black and Latinx Veterans.
Methodology: Using racial/ethnic stratification we will survey 1,050 Veterans at 25 VA medical centers on
their experience of trust in VA. One hundred and fifty Veterans will also be asked open-ended questions about
sources of trust/distrust across 12 domains of health care. We will use survey and qualitative methods to
analyze the data from Aims 1 and 2, respectively. A toolkit development group will examine the Veteran
recommendations and using a modified Delphi approach will create a toolkit designed to improve Black and
Latinx Veterans’ trust in VA.
Implementation/Next steps: We will partner with the Office of Health Equity, the Veteran Experience Office,
the office of Analytics and Performance Integration, and vendor Dynamic Integration Services to ensure that
the VA is thoroughly trained and responsive to the recommendations resulting from this work.

Public health relevance
Minority Veterans had more distrust in their VA healthcare than White Veterans, even before the COVID-19 pandemic. Trust in healthcare is important because patients who have more trust in their healthcare have better health outcomes. In general, Black and Latinx Veterans are more vulnerable to the COVID-19 pandemic. Minority Veterans’ higher infection rates, worse general health status, and lower access to virtual healthcare through technology might further decrease their trust in their VA healthcare system. This study will survey 1,050 Black, Latinx and White Veterans who receive their healthcare from 25 VA medical centers to measure their trust in VA healthcare. One hundred and eighty of those Veterans will also answer open-ended questions to help VA understand male and female minority Veterans’ trust in the VA and get their recommendations for improvement. We will develop a toolkit from those recommendations for VA to improve minority Veterans’ healthcare experiences.